Circuits regulating arousal and behavioral responses to visual threats

PROJECT SUMMARY
The ability to appropriately respond to threats is crucial for survival. Literature has long suggested that
arousal and attention, mediated by the neuromodulators norepinephrine (NE) and acetylcholine (ACh),
influence sensory processing. NE and ACh release affect behavioral states and are released in response to
novelty, attentional effort, and threat. However, the unique contributions of these neuromodulators in regulating
behavioral states, and circuits which might underly the release of these neuromodulators in response to salient
threat stimuli, remain unclear. It is possible that salient visual stimuli alter neuromodulator release through
direct projections of the superior colliculus, resulting in enhanced sensory processing in response to threat, but
this circuit has not been directly tested. Height threat is an evolutionarily conserved, ethological visual threat
behavior that can be used to study neural circuits underlying threat processing. The visual cliff test is an optical
illusion which generates the appearance of a cliff. Both rodents and human infants avoid crossing the threshold
of the visual cliff. In rodents, this behavior depends on visual perception and binocular vision. Humans exposed
to virtual height threats exhibit increased physiological arousal which correlates with perceived height level. We
developed a virtual visual cliff task to study the relationship between neuromodulators, attention, arousal,
sensory processing, and threat-related decision-making. Mice climb down a pole towards a virtual cliff and exit
to one of four quadrants, one which appears close and three which appear distant. Threat level is modulated
by altering the apparent distance between the close and distant quadrants. Head-mounted eye tracking will be
used to measure arousal via pupil diameter and attention via gaze and head direction, which will allow us to
differentiate the roles of attention and arousal in visual processing and decision-making. This research will
elucidate how neuromodulators influence sensory encoding and behavior in response to visual threats, as well
as the role of sensory systems in engaging neuromodulator release to enhance sensory processing in
response to salient visual threats.

Public health relevance
PROJECT NARRATIVE The neuromodulators norepinephrine and acetylcholine are correlated with changes in attention and arousal and are known to alter sensory processing, suggesting that when organisms encounter a threatening stimulus, direct projections from sensory circuits may alter neuromodulator release to enhance sensory processing and guide threat-avoidance behaviors. Understanding these circuits are critical for better understanding how humans respond to threats, but they have not been directly tested. Using a novel evolutionarily-conserved height threat behavior, optical tools for measuring and manipulating neuromodulator activity, and pupil diameter as a measure of arousal, this project will determine the circuits which regulate neuromodulator release in response to threatening stimuli and how they control behavioral responses to threat.